CORE GRANT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The core subproject was established to handle central administrative issues relating to the functioning of the Resource. The Annual Flow Course, conferences, interactions with collaborators, service users, the Advisory Committee, NFCR staff meetings, executive committee meetings, preparation of reports and monitoring the Resource budget are handled by the NFCR Core Grant.